EFFICACY OF RIFAPENTINE AND INH AS THERAPY FOR PULMONARY TUBERCULOSIS

This is a multi-center, prospective, open label, comparative trial of two treatment regimens for tuberculosis. Once weekly Rifapentine and INH will be compared to twice weekly Rifampin and INH therapy in the continuation phase of treatment for pulmonary tuberculosis.